Parasite polymorphism and host immune response in cutaneous leishmaniasis outcome

Summary
Leishmania braziliensis infection may cause a high spectrum of clinical manifestation, including the more
prevalent form, cutaneous leishmaniasis (CL). Inflammatory response is a hallmark of CL and high levels of
TNF, presence of CD8+ T cells and mononuclear phagocytes are associated with skin ulcer development in
these individuals. In our endemic area we have been able to identify individuals with a non-ulcerated lesion
(papule), with regional lymphadenopathy and positive Leishmania skin test. These individuals report less than
15 days of disease evolution and are considered to have early CL (ECL). Our preliminary data shows that ECL
patients have more parasites than CL ones and are able to mount inflammatory response to Leishmania
antigen in in-vitro assays. A major problem in areas of L. braziliensis transmission regards therapeutic failure.
Studies from our group and others show that up to 30% of CL (with ulcerated lesion) patients fail treatment with
pentavalent antimony, drug of choice of Brazilian Minister of Health to treat leishmaniasis. The early treatment
of the majority of infectious disease benefits the patients, decreasing time to cure and relapses. However, we
have been reporting that in ECL the therapeutic failure is up to 70%. Interestingly, our preliminary data show
genetic differences between most parasites isolated from ECL and those from CL. Our main hypothesis is that
high rates of therapeutic failure in ECL is associated with drug resistance and lack of regulation of
inflammatory due to high amounts of Leishmania, thus contributing to ulcer development. To investigate the
mechanisms associated with therapeutic failure we will establish a cohort of ECL and CL individuals admitted
in the health post of our endemic area. In the Aim 1 of the present proposal we intend to assess parasite
genetic polymorphism and resistance to leishmanicidal drugs, and quantify host and Leishmania genes
associated with therapeutic failure. In Aim 2 we will investigate immune mechanisms involved of therapeutic
failure. For that we will determine the contribution of cells, soluble factors, cell receptors and regulatory
mechanisms in ECL and CL before and during therapy. In Aim 3 we will study the ability of eicosanoids
metabolites of Omega-3 fatty acids (DHA, EPA and Resolvins) to regulate inflammatory response in ECL and
CL. The early identification of individuals that will fail treatment will allow the early use of another choice of
therapy.

Public health relevance
Project narrative In the current proposal will investigate whether host and parasite factors are responsible for poor outcome (therapeutic failure) in cutaneous leishmaniasis patients in the early and late stages of the disease. Our hypothesis is that parasite resistance, in addition to parasite-driven inflammatory response, mediates tissue damage and skin ulcer development in these individuals.